Collaborative Modeling for Assessment and Optimization in Public Health

Project V: Collaborative Modeling for Assessment and Optimization in Public Health proposes work with public health partners to address two key aspects of their work ~ burden/severity estimation and optimization of interventions - using a range of modeling approaches.